Circadian Clock and Myc-dependent Regulation of Cellular Transformation

The supplement instructions for PAR-22-114 state: “At a minimum, the Research Strategy
section should be completed and must include a summary or abstract of the funded parent
award or project. Other sections should also be included if they are being changed by the
proposed supplement activities.”
The original Project Summary / Abstract document has not changed as a result of the
proposed supplement activities.

Public health relevance
The supplement instructions for PAR-22-114 state: “At a minimum, the Research Strategy section should be completed and must include a summary or abstract of the funded parent award or project. Other sections should also be included if they are being changed by the proposed supplement activities.” The original Project Narrative document has not changed as a result of the proposed supplement activities.